PARALLEL TRANSMIT ARRAY FOR 7T MRI SYSTEM

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. The proposed upgrade of the 7 Tesla imaging resource will substantially impact the fundamental understanding, early diagnosis, and development of novel therapies for host of human disease.